National Capital Consortium for Pediatric Device Innovation 2.0

ABSTRACT
NCC-PDI’s mission is to facilitate the development and commercialization of devices that are indicated for use
in pediatric patients or that are intended to treat, diagnose, or cure diseases from which pediatric patients
suffer. The Consortium has served as an accelerator to medical device innovators that intend to label their
device for use, in the United States, in the general pediatric population or a subpopulation. The Food and Drug
Administration’s report to Congress on “FY 2016 Premarket Approval of Pediatric Uses of Devices” indicates
that over a 9-year period (2008-2016), an average of almost nine devices were approved per year that were
indicated for pediatric patients; this equated to an average of 20.5 percent Pre-market Approvals (PMAs) and
Humanitarian Device Exemptions (HDEs) over this time. This represents a formidable progress that was
achieved thanks in large to the Pediatric Medical Device Safety and Improvement Act (PMDSIA) of 2007. A
closer look at the data, however, suggests that the majority of these approved devices are labeled for the
adolescent subpopulation (12 years through 21 years of age) in addition to older adults. There still remains a
significant unmet need for devices labeled for subpopulations of neonates (birth until 1 month of age),
infants (1 month until 2 years of age), and children (2 years until 12 years of age). NCC-PDI’s long-term
goal under this RFA is to contribute to the national effort to address this gap and help bring more devices to
market. Our short-term and operational goals are to continuously enhance our capabilities in providing expert
advising and support services to innovators of pediatric medical devices, focusing on the total product life cycle
for medical devices from concept, through pre-market development, to commercialization. We will reach our
long-term and short-term goals by achieving the following specific aims. Specific Aim 1. Enhance the pipeline
of high-growth pediatric device entrepreneurs with special considerations given to those who focus on the
unmet needs of subpopulations of neonates, infants, and children. Specific Aim 2. Foster the advance of
pediatric medical devices through access to a platform of experienced business, regulatory, reimbursement,
medicine & science, engineering & prototyping, and trials design. Specific Aim 3. Through implementation of
demonstration projects, develop, verify and operationalize methods of evidence generation and data usage,
and demonstrate scalability across diverse devices and diseases. Our Consortium consists of lead members
(Children’s National Health System and University of Maryland), members (BioHealth Innovation, MedTech
Innovator, HealthCore/NERI, and Resnick, Chodorow, & Associates), and extended members (Smithwise,
Cadence, I-ACT, PEDSnet, Bear Institute/Cerner, Digital Infuzion, Epidarex, Medical Murray, SFA Regulatory,
CTSI-CN, CALCE, M-CERSI).

Public health relevance
NARRATIVE The objective of the National Capital Consortium for Pediatric Device Innovation is to contribute to the national effort to address unmet need for available medical devices for children. We will provide expert advising and support services to innovators of pediatric medical devices, focusing on the total product life cycle for medical devices from concept to commercialization.